Administrative Core

Administrative Core-Abstract
The overall goal of the Administrative Core is to integrate the multiple components of this multi-institutional,
interdisciplinary team science proposal. The approach focuses on three specific aims, to manage the research
endeavor, to manage the finances and reporting, and to form a coherent community of scientists. The
Administrative Core will be integrated within the existing professional administration of the Center for Brain
Science at Harvard University, augmented by a full-time administrator dedicated to this project. This
Administrative Core will be organized within a clear governance structure and explicit procedural guidelines will
be put in place for decision-making and conflict resolution.

Public health relevance
The research plan we propose aims at a comprehensive multi-level understanding of how the brain and the body interact to respond adaptively to a potentially harsh and unforgiving environment. Among the many internal factors that are under constant homeostatic regulation, we focus on the bi-directional dialogue between the brain and the heart, since the cardiovascular system and its role in regulating oxygen delivery is one of the most critical and universal control systems within the animal kingdom. A central aspect of our approach is the generation of a complete brain and body connectome of the larval zebrafish, a map which will be the first ever generated in a vertebrate, and which will be critical in both testing the validity of many extant models, and perhaps discovering new pathways within the interconnected neural circuits that serve the changing needs of the body during behavior.